Experimental Irradiation (EI)

The Experimental Irradiation Shared Resource (EI-SR) provides access to state-of-the-art equipment and
expert consultation for Rogel Cancer Center (Rogel) members undertaking radiation therapy studies primarily
in mouse and rat models and cell lines. First established in 1991, this SR has been approved and funded
continuously by the NCI CCSG since its inception. The experience and expertise of the EI-SR Director and
Managing Director offer Rogel investigators information on dosage and treatment regimens, particularly in
animal studies and with a knowledge of standard clinical radiotherapy, to ensure experimental resources are
used in an optimal way. EI-SR services are critical to Rogel members interested in radiation biology and
radiation therapy, as well as those for whom radiation serves as a research tool.